University of Pennsylvania Patient-derived Xenograft Development and Trials Center

The goal of the Administrative Core of the University of Pennsylvania PDX Development and Trials Center is primarily to facilitate innovative translational science that will accelerate the application of new discoveries to the clinic for cancer patients. This will be achieved through a combination of enhancing both the development of unique PDX models at UPENN and through facilitating interaction with the PDXNet. The Administrative Core will be responsible to make sure that the UP-PDTC acts effectively as a research unit of PDXNet. The primary responsibilities of the Administrative Core are to provide scientific leadership, administrative services, and financial oversight, as well as to function as a communication hub for all UP-PDTC-related activities. The Administrative Core will support investigators and personnel in Projects 1-2, the PDX Core, the Pilot Projects and Trans-Network Core, and the Biostatistical Core. The Administrative Core will arrange at least annual meetings of the SAB of the UP-PDTC. Of note, the Administrative Core coordinates all efforts in support of providing patient representation and access to tissue samples and PDX models. The Administrative Core provides centralized organization and support for all groups using Core facilities, and helps each group stay informed about activities, meetings, opportunities, and other information pertinent to the UP-PDTC. The Administrative Core will be responsible for communication with PDXNet personnel (PDXNet Steering Committee) as well as NCI personnel and will provide support for all collaborations. In particular, the Administrative Core will facilitate interactions between UP-PDTC personnel and the PDXNet Data Commons and Administrative Center. Continuity of support provided by the staff will result in efficient and effective administration for the UP-PDTC.

Public health relevance
Human cancers are a heterogeneous group of diseases many of which can be highly fatal. Increasing knowledge suggests that the best way to study the biology and therapy of human cancers is by growing primary human cancer tissue in immunocompromised mice, a so called xenotransplantation model. The Administrative Core will work with the PDXNet and the University of Pennsylvania Xenotransplantation program to develop new models for study of human cancers.